Texas Doctoral Bridge Program

PROJECT SUMMARY
Texas State University (TxSt) and its partner in this Bridge-to-the-Doctorate Program application, the University
of Texas Health Science Center at San Antonio (UT Health San Antonio; UTHSA), are both designated Hispanic-
Serving Institutions and actively support and promote various programs targeting students from historically
marginalized groups (HMGs). We are partnering for a new T32 institutional training grant, the Texas Doctoral
Bridge Program (TDBP), which aims to increase the diversity of the biomedical workforce by preparing and
recruiting outstanding M.S. students from TxSt for competitive and high quality biomedical Ph.D. programs, such
as that found at UTHSA. Over the last ten years, TxSt has established an excellent record in training biochemistry
M.S. students for doctoral programs. In particular, NIH support of these trainees through an R25 grant program
strongly impacted the Biochemistry M.S. program by reducing overall time-to-degree while simultaneously
increasing the proportion of students from HMGs (from ~20% to ~50%). More than 70% of the NIH-supported
trainees from this R25 program were bridged to doctoral degree programs with many completing the Ph.D. and
transitioning to postdoc positions or other careers of choice. This new T32 will support to up to 14 eligible students
per year, who are enrolled in thesis-based M.S. degree programs in departments across the College of Science
and Engineering at TxSt, to include biology, biochemistry, chemistry, mathematics, and computer science tracks.
Concurrently, this collaborative training program will foster a strong research and training relationship between
faculty at UTHSA and TxSt. We anticipate that inter-institutional rigorous research thesis projects that utilize the
scientific resources at UTHSA will enhance the capability of trainees from HMGs at TxSt to be competitive for,
gain admission into, and thrive within high quality research doctoral programs in biomedical science. Our
program objectives are to: 1) increase the diversity and inclusion of HM students in thesis-based, biomedical
M.S. degree programs at TxSt, 2) develop trainee skillsets to ensure the transition to Ph.D. programs and for
long-term professional success in biomedical research careers, and 3) mentor the mentors by building a
community of excellence for effective, rigorous, and culturally aware mentoring.

Public health relevance
PROJECT NARRATIVE The goal of the Texas Doctoral Bridge Program, a formal partnership between Hispanic Serving Institutions Texas State University (master's degree granting institution) and the University of Texas Health Science Center at San Antonio (UTHSA) (Ph.D. granting institution), is to increase the number of students from historically marginalized groups (HMGs) who complete doctoral studies in the biomedical sciences. There is an urgent need to strengthen and diversify the biomedical research workforce to address disparities linked to race/ethnicity and socio-economic status amongst other factors. Through a series of programmatic activities involving rigorous didactic preparation and integrated research training, M.S. students from HMGs at Texas State will be bridged into competitive Ph.D. programs at UTHSA or other first-rate biomedical institutions.